Polygenic risk in familial epilepsy

PROJECT SUMMARY/ABSTRACT
Dr. Colin Ellis is an Assistant Professor of Neurology at the University of Pennsylvania with clinical expertise in
both epilepsy and genetics. His long-term goal as a physician-scientist is to translate genetic discoveries into
clinically meaningful tools that improve the care of people with epilepsy across the lifespan.
Epilepsy is a highly heritable disorder and often runs in families. Recent progress identifying the genes that
cause epilepsy applies mostly to severe pediatric epilepsies with de novo (not inherited) mutations. Familial
epilepsy presumably also has a genetic basis, yet most families with epilepsy do not have an identifiable single
gene mutation. This proposal tests the hypothesis that familial epilepsy is caused by the aggregate effects of
many variants (risk alleles) distributed across the genome. Experiments will apply polygenic risk analysis to a
unique cohort of over 1,000 multiplex epilepsy families. The specific aims are (1) determine the genome-wide
contribution of polygenic risk to familial epilepsies, (2) identify novel and candidate biological pathways that
contribute to familial epilepsy, and (3) quantify the transmission of polygenic epilepsy risk within families using a
novel analytic method. The results of this project will contribute to understanding the genetic basis of familial
epilepsy, the biological pathways that are potential treatment targets, and the future development of clinical tools
that use patients’ genetic data to improve the diagnosis and management of epilepsy.
The proposal builds on Dr. Ellis’s prior research on the heritability of phenotypic traits within familial
epilepsies, and extends that research into the analysis of genomic data. His training plan will develop his
expertise in genomic research methods, statistical genetics, and bioinformatics. He will also gain training and
skills in clinical trial design and implementation, positioning himself for the future clinical applications of this and
other genetic research in his dedicated neurogenetics clinics. Dr. Ellis’s team of mentors and advisors at the
University of Pennsylvania (Drs. Hakon Hakonarson, Laura Almasy, Kai Wang, and Brian Litt) provide specific
expertise in his areas of skill development and strong track records of mentorship. He will also leverage his
existing relationships with external advisors through the international Epi4K Consortium (Drs. Samuel Berkovic,
Michael Epstein, and Ruth Ottman) who are among the world leaders in his field of epilepsy genetics research.
Dr. Ellis’s clinical background in epilepsy and genetics, with the additional support of this career development
award and his unique mentorship opportunities, will position him to succeed as an independent physician-
scientist focused on using genetic discoveries to improve the lives of people with epilepsy.

Public health relevance
PROJECT NARRATIVE Epilepsy is a chronic, debilitating neurological condition that affects 50 million people worldwide. Although it often runs in families, the genetic causes of familial epilepsy are not well understood. This research will help us understand the genetic causes of familial epilepsy, identify biological mechanisms that could be potential treatment targets, and develop new tools that use genetic information to improve the diagnosis and treatment of people with epilepsy.